Development of New Proteomics Technology and its Application to Study Cellular Organization

Deciphering the Relationship Between mRNA and Protein Dynamics in a Developing
Proto-Vertebrate
The broad goal of the parent award (Development of New Proteomics Technology and its
Application to Study Cellular Organization) is to advance quantitative proteomics technology
and apply it to obtain a systems level understanding of cellular organization. Recently, we have
demonstrated that TMTproC significantly increases sensitivity and multiplexing capacity of the
complement reporter ion approach while making these approaches compatible with a broad set
of mass spectrometers (Johnson, 2021). We have also worked to improve access to high-
quality proteomics data by integrating TMTproC with ion-trap only instruments which cost 80%
less than ones typically used for multiplexed quantitative proteomics. We have successfully
leveraged our proteomics technology development for multiple collaborations (Crapse, 2021;
Hart, 2020; Cao, 2020) which has advanced our understanding of cellular organization. One
focus of the lab is to better understand developmental progression (Nguyen, 2021; Keber, 2021;
Nofal, 2021). Recently, we have published a preprint showing that, in frog embryos, nuclear
proteins access the nucleus in a temporal order set via importin affinities during development,
thereby acting as an elegant timing mechanism to control the onset of their downstream
functions (Nguyen, 2021). Extending beyond our work in developmental biology, we have
developed methods that allow us to parameterize all aspects of protein abundance control on a
global scale through multi-omics integration of transcription, translation, and degradation. Key to
these advances was developing new methods that allow measurement of perturbation-free
protein turnover. So far, we have applied these methods to E. coli and yeast (Gupta, et al., in
preparation), and Alex Frese is expanding these approaches to the developing Ciona embryo
with the goal of generalizing these techniques to complex higher organisms such as Xenopus
and Drosophila.

Public health relevance
Project Narrative The aim of this supplement is to decipher the relationship between mRNA and protein dynamics in a developing proto vertebrate. This will provide us with fundamental insight into regulation in early embryogenesis and associated developmental abnormalities.